RENAL AND CARDIOVASCULAR EFFECTS OF PSYCHOLOGICAL STRESS

Normal subjects and individuals with intermittent hypertension have their blood pressure responses and renal electrolyte excretion measured in response to laboratory stressors and real-life events while eating low, normal and high sodium diets. The results should provide information concerning the interrelationships between sodium intake and stress in the causation of hypertension.